53BP1 regulates genome biology and cellular physiology through liquid phase separation

The function of nuclear DNA is not only determined by its sequence, but also depends on its three dimensional
(3D) structure. A particular type of DNA in eukaryotes is called heterochromatin, which refers to as tightly
packed DNA structure in the nucleus. Heterochromatin plays a critical role in genome function including DNA
structural maintenance, chromosome segregation, epigenetic inheritance, DNA replication, repair and
transcription. Recently, increasing evidence suggests the involvement of a new biological process called liquid-
liquid phase separation in the formation and function of heterochromatin. Liquid-liquid phase separation, whose
concept was borrowed from polymer sciences, is a unique process that involves the formation of
membraneless liquid droplets by proteins and nucleotides when their concentration have reached a threshold.
These liquid droplets enable the assembly and disassembly of functional protein-based organelles within a
cellular compartment following environmental cues. Hence, liquid-liquid phase separation has facilitated our
understanding of fundamental cellular information processing, cellular homeostasis, and cellular physiology.
Recently, we unexpectedly identified a new player, human 53BP1, in regulating the heterochromatin integrity
through liquid-liquid phase separation. 53BP1 was previously known as a critical player in regulating the DNA
double strand break repair. However, we discovered that the protective role of 53BP1 in both the structure and
the function of heterochromatin is distinct from its canonical activity in DNA double strand break repair. Hence,
our studies opened a new research paradigm for this important protein in signaling, biology and cellular
physiology. The goal of this proposal is to establish this new research field by addressing several unanswered
important questions regarding this new function of 53BP1. These include the molecular basis by which 53BP1
forms the liquid droplets and its significance in biology, genome biology, and cellular physiology. We have used
mass spectrometry to identify components in the liquid droplets formed by 53BP1. We will interrogate their
functions in this application. By assembling an interdisciplinary team consisting of experts on molecular and
cellular biology, proteomics, computational bioinformatics, and next generation sequencing, we will use a
combination of cell biological, molecular, biochemical, genetic, morphological, and chemical approaches to
answer these questions. Our studies will illustrate a previously uncharacterized function of 53BP1 and a novel
interplay between 53BP1 and heterochromatin and determine their impact on genome stability, facilitating our
understanding of fundamental cellular information processing, cellular homeostasis, and cellular physiology.

Public health relevance
Identifying molecular mechanisms underlying chromosome maintenance and gene expression in eukaryotes is critical for our understanding of genome biology and cellular homeostasis and physiology. This proposal will investigate our recent discovery about a novel regulatory mechanism of human genome by a protein called 53BP1. Upon completion, this study will reveal innovative insights into the maintenance of DNA structure, transcriptome, and genome stability, representing a conceptual leap in our understanding of biology and cellular physiology.